Differential resistance mechanisms to monofunctional vs bifunctional alkylating agents in glioma

Project Summary
Resistance to alkylating agents, including monofunctional temozolomide (TMZ) and bifunctional CCNU,
remains a major obstacle to improving outcomes for patients with glioma. An important difference between
these therapies is that monofunctional alkylators form several types of alkylated nucleotides, while bifunctional
alkylators form highly toxic interstrand crosslinks (ICLs). We hypothesize that CCNU and TMZ kill glioma
cells through different mechanisms, leading in some instances to different patterns of resistance and
independent effects on outcome that may be leveraged for therapeutic benefit. Resistance to both
agents can result from expression of the methyl guanine methyl transferase (MGMT) protein. TMZ resistance
can also result from mismatch repair deficiency (MMR-d). Resistance to CCNU has not been systematically
characterized but involves members of several DNA damage repair (DDR) pathways. We will extend previous
work by systematically probing DDR pathways using varied and representative models and state-of-the-art
genomic and functional genomic technologies to test the following hypotheses:
Aim 1: TMZ resistance via MMR-d predicts sensitivity to CCNU. Our recent work suggests that MMR-d
does not cause CCNU resistance. Using isogenic and patient derived models, we will determine which TMZ
resistance mechanisms also result in resistance to CCNU and assess changes in mutational signatures after
CCNU treatment. We will then use competition assays and barcoding assays to test the hypothesis that the
combination of TMZ and CCNU may provide therapeutic benefit over monotherapy in some contexts.
Aim 2: Repair proteins that engage CCNU-induced ICLs determine sensitivity to CCNU. We will test the
effect of transcriptional activation of genes known to contribute to ICL repair on CCNU resistance. We will then
determine if chemical inhibitors of those proteins can improve CCNU efficacy. Finally, we will perform complete
genomic characterization of gliomas pre- and post- CCNU treatment to characterize mutational and SV profiles
of CCNU resistance as well as the effect of CCNU treatment on genomic instability. This proposal will shed
light on differences in resistance to mono- and bi-functional alkylating agents that may be clinically
exploitable to improve outcomes for patients with glioma.
This training at the Broad Institute and Dana Farber Cancer Institute will provide Dr. Simona Dalin skills of a
faculty member, including systematic and genomic techniques, computational analysis of genomic datasets,
algorithm development, and DDR biology. She will also mentor students in aspects of the project.

Public health relevance
Project Narrative Despite treatment with alkylating agents such as temozolomide and lomustine (CCNU), malignant glioma has a poor prognosis. We aim to better understand how resistance to these agents results from deficiencies in various DNA damage repair pathways. This knowledge will aid in design of combination regimens that target chemotherapy resistance.